Type 2 diabetes induced chronic inflammation on stroke outcome

Type 2 diabetes (T2DM) not only increases the risk of stroke, but also worsens the stroke
outcome. Poor blood perfusion, hypercoagulability and chronic inflammation are known to be
contributing factors. Complement activation products, especially C3 opsonins and the C3a/C5a
anaphylaxis, have been implicated in promoting secondary injury following cerebral
ischemic/reperfusion. The involvement of complement in the pathogenesis of insulin resistance
and complications associated with type 2 diabetes is also well documented. However, how
complement predisposes the brain to exacerbated ischemic injury and functional impairment is
not well understood, let alone which cell types are involved in propagating complement-
mediated inflammation. Via single cell transcriptomics we detected elevated expression of
complement genes in the brain myeloid cells of mice with T2DM prior to the onset of stroke,
including components of the classical pathway (c1qa-c), the anaphylatoxin receptors (C3ar and
C5ar), and complement receptor 3 (CR3, itgam), as well as a number of chemotaxis-related
molecules. Multiphoton imaging confirmed that T2DM mice exhibited poor collateral flow,
accompanied by increased WBC-platelet aggregates in cerebral vessels together with increased
leukocyte rolling, resulting in increased infiltration of neutrophils into brain parenchyma. We here
propose to investigate the role of complement in promoting worse stroke outcomes in T2DM
mice. Our first aim will determine the functional role of P-selectin and the anaphylatoxin
receptors C3aR and C5aR in T2DM promoted transmigration of peripheral myeloid cells into
brain after stroke. Aim 2 will determine the spatial and temporal expression of complement C3 in
brains after stroke, and experiments will also delineate the functional effect of C3 from infiltrating
versus brain resident glia cells on neuronal loss and stroke outcome. Aim 3 will investigate the
role of microglia specific complement receptor 3 (CR3) in aberrant neuronal/synaptic loss and
the functional role of this receptor in determining outcomes in T2DM and control mice. With
comprehensive and effective approaches incorporating multidisciplinary techniques, this project
will provide significant insight into the mechanisms underlying T2DM-mediated inflammation in
the context of stroke.

Public health relevance
Human stroke patients with type 2 diabetes often sustained more severe symptoms and worse functional outcome and one crucial factor to be blamed for this predicament is the chronic inflammation caused by type 2 diabetes that primed the immune system for a severe reaction to stroke. We found that in mice with type 2 diabetes prior to stroke there were already increased level of molecules can help the immune cells to traffic into the brains including those belong to the complement system. The goal of this study is to understand the molecular pathways leading to the activation of this inflammatory response that predisposes the brain to a much worse stroke outcome.